CORE--ADMINISTRATIVE AND BIOSTATISTICS

The Administrative and Biostatistics Core will provide the infrastructure for the Botanical Research Center (BRC). It will support the research objectives of the BRC by facilitating communication and collaboration among members of the research team and between Center researchers and the applicant's tri-institutional campus (MSKCC, Cornell-Weill, and Rockefeller University). The Administrative Core will be responsible for the overall functioning of the Botanical Research Center and for its operational efficiency. It will maintain oversight of financial management and the ongoing coordination of investigators and research activities. This Core will organize meetings of the External Advisory Board and Internal Steering Committee, and manage the pilot research and career development programs. The Administrative Core will house biostatistical, data sharing, and related services for all Center projects. It will provide research pharmacy expertise to manage both the selection of botanical study agents and the work toward meeting regulatory requirements for those agents. In sum, the Administrative Core will: Provide leadership, infrastructure and administrative support to the community of investigators in the proposed Center; Assure operational efficiency, financial management and fiscal integrity; Organize and coordinate meetings of investigators and campus-wide programs to share Center work and promote interest in botanicals research.; Assure continuing interaction and collaboration among Center participants; Implement External Advisory Board and Internal Steering Committee activities; Evaluate scientific progress regularly; House efforts related to Pilot research, training and development, promotional activities and grants; House biostatistical and botanical regulatory support services.; Serve as the problem solving agency for Center issues of any kind.